PHASE I TRIAL OF PIROXANTRONE IN PATIENTS WITH ADVANCED CANCER

Piroxantrone, an anthrapyrazole current in Phase II testing, is of interest due to its potential for combining an anthracycline's broad antitumor efficacy with a lower risk of cardiotoxicity.